Using Brain Ultrasound Imaging, Microcirculation and Parenchymal Stiffness to Assess for Mechanisms of Early Neurodevelopmental Disparities among Infants HIV-Exposed Uninfected

Summary/Abstract
Each year nearly one million infants are born after fetal exposure to HIV and maternal antiretroviral treatment
(ART) yet remain HIV-uninfected. Our work and that of others has shown that infants HIV-exposed uninfected
(HEU) are at higher risk of poorer neurocognitive and developmental outcomes compared to infants born HIV-
unexposed (HU), even when maternal HIV viral suppression is maintained throughout pregnancy. Infants HEU
are at higher risk of motor and expressive language delays compared to infants HU. While neurocognitive and
developmental outcomes are driven by the complex interplay of biological, social, and structural factors, early
life predictive correlates of poor developmental and neurocognitive outcomes are urgently needed to identify
infants who may benefit from early interventions. Brain ultrasound is the initial imaging modality of choice for
diagnosis and monitoring of many neonatal brain conditions, including exposure to infections such as
cytomegalovirus. Major advantages of ultrasound include its safety, relatively low cost, and that it can be
repeated as often as necessary with limited need for patient cooperation. Additionally, advancements in
ultrasound technology have evolved into simpler, user-friendly, and more portable equipment that allow studies
to be performed by non-sonographers/non-radiologists. Furthermore, with advanced ultrasound technology,
including high-resolution microvascular imaging (MVI), shear-wave elastography, and quantitative texture
analysis (i.e., radiomics), it is possible to assess not only for structural neonatal and infant brain differences but
also tissue differences. Importantly, these advanced ultrasound methods offer the potential to detect differences
at an earlier age compared to findings reported with use of magnetic resonance imaging (MRI) in older children
who are HEU, recognizing that MRI findings have been associated with neurodevelopmental delays. Testing
during the first six months of life provides the opportunity for earlier identification of at-risk infants and provision
of earlier interventions. Our preliminary work using basic ultrasound imaging in the neonatal period has identified
that neonates who are HEU have shorter corpus callosum length than neonates who are HU, a brain structure
known to influence language development, motor skills and cognition. This study will 1) evaluate if differences in
corpus callosum length and parenchymal homogeneity identified in our birth cohort persist using low field MRI
and correlate with developmental delays at 2 years of age; 2) and using more advance ultrasound features,
determine if brain structural, texture, microcirculatory and elasticity differences between infants HEU and those
who are HU are associated with volumetric and signal intensity differences on brain low field MRI at 1-year of
life; and 3) determine if specific brain ultrasound biomarkers identified at birth are associated with
neurodevelopmental outcomes at 2 years of life. Starting life HIV-free among infants who are HEU, has not
ensured comparable neurodevelopmental outcomes to that of infants who are HU. The proposed science will
position us to identify early brain biomarkers associated with infants in need for early interventions.

Public health relevance
Nearly one million infants are born HIV-exposed uninfected (HEU) annually worldwide, including approximately 4,000 infants in the United States, and these infants are at risk for poor neurocognitive and developmental outcomes compared to infants born to persons without HIV. A viable and scalable screening mechanism is urgently needed to identify infants and young children who are HEU and in need of early interventions to reach their full neurocognitive and developmental potential. We will employ basic and advanced infant brain ultrasound imaging to assess for structural, texture, microcirculatory, and parenchymal stiffness differences that can identify infants in the United States and globally who are HEU and at-risk for poor developmental outcomes, correlating findings with magnetic resonance imaging at 1-year of life and assessing for associations with neurodevelopmental outcomes at 2-years of life in this Botswana-based study.